COMBINATION OF MRI AND FOCUSSED ULTRASOUND FOR INTERVENTIONAL PURPOSES

The purpose of this project is to accomplish local temperature elevation using focused ultrasound (FUS) guided by MRI. This method can be used for tumor ablation and in gene therapy.